Tumor Selective Apoptosis by TRAIL

c-FLIP is a key anti-apoptotic factor that is over-expressed in many tumors and blocks the apoptotic machinery by interfering with FADD, caspase-8 and DR5. Significant evidence demonstrates that c-FLIP over-expression in tumors is a major cause of resistance to TRAIL-induced apoptosis. Therefore, strategies to inhibit c-FLIP action and to overcome c-FLIP-induced resistance in tumor cells may lead to novel and more effective therapies. We have discovered a bioactive peptide, ApoFLIP that antagonizes with c-FLIP and reinstates the apoptotic machinery in c-FLIP expressing cells. The major goal of this proposal is to develop and characterize drug-like variants of this peptide. These agents could provide significant enhancements in the current therapeutic strategies in hematological malignancies and other tumors that show resistance to apoptosis-inducing therapeutics.

Public health relevance
Research Narrative: Resistance to cancer therapeutics is one of the major hurdles in oncology. The chief cause of this resistance is evasion of apoptosis due to altered apoptotic signaling. This proposal focuses on characterization of a novel bioactive paptide that we have discovered that could remove a major apoptotic block in cancer cells and sensitize them to apoptosis.